Novel mechanisms of B cell tumorigenesis and relapse

Abstract:
B cell malignancies comprise more than 50% of blood cancers, approximately 85% of lymphomas, and all
myelomas. Despite recent treatment advancements that significantly prolong patient survival, many B cell
malignancies remain incurable, highlighting the necessity for a deeper understanding of the disease
pathogenesis. During the past 3 decades, research efforts on the pathogenesis of B cell malignancies have
been primarily focused on the genetic and epigenetic alterations as well as their oncogenic signaling pathways.
Recent endeavors have advanced the understanding of the influence of stromal cells and immune cell subsets
on malignant B cells in the tumor microenvironment. This new R01 project aims to elucidate novel paradigm-
shifting mechanisms of B cell tumorigenesis, treatment resistance, and relapse driven by commensal bacteria-
derived molecules. We reason that commensal bacteria outnumber human cells in the body and constitute the
largest pool of antigens for B cell antigen receptors (BCRs) and ligands for Toll-like receptors (TLRs)
expressed on B cells in humans. Although commensal bacteria have been implicated in the carcinogenesis of
other human cancers such as colon, colorectal, pancreatic, liver, lung, and breast cancers, B lymphocytes are
the only cell type of the human body that expresses specific antigen receptors (BCRs) and can produce
specific antibodies in response to commensal bacterial antigens. Even in the absence of commensal bacteria
transmigration or systemic infection, commensal bacterial antigens and ligands, in the format of soluble
molecules or large fragments, can be released from commensal bacteria via secretion, shedding, digestion, or
bacterial death-associated decomposition. Such commensal bacteria-derived soluble molecules or large
fragments, including antigens and ligands, may gain access to various B cell subsets in lymphoid organs
through the blood circulation and lymphatic drainage. However, investigation of commensal bacteria-derived
molecules in B cell tumorigenesis is lacking. We will address this critical gap in cancer research. Based on our
proof-of-concept preliminary data, we will test the central hypothesis that commensal bacterial molecules can
engage BCR and TLR signaling to drive B cell tumorigenesis, treatment resistance, and relapse. We will
further exploit such new knowledge to develop novel diagnostics and therapeutics to improve early detection
and treatment of B cell malignancies and to prevent relapse. Such commensal bacteria-based diagnostics and
therapeutics have mechanisms of action distinct from and complementary to currently available diagnostics
and therapeutics, and therefore can be easily integrated into the current standard-of-care system to transform
the management landscape of B cell malignancies and improve patient outcome.

Public health relevance
Relevance to Public Health Statement B cell malignancies are significant health issues both in the US and worldwide, constituting more than 50% of blood cancers, approximately 85% of lymphomas, and all myelomas. Despite recent treatment advancements that significantly improve patient survival, many B cell malignancies remain incurable. This new R01 project aims to elucidate novel paradigm-shifting mechanisms of B cell tumorigenesis, treatment resistance, and relapse driven by commensal bacteria-derived molecules, which can be exploited to develop new diagnostics and therapeutics to transform the management of B cell malignancies.